Mobile sensors in cancer care: Patient and provider perspectives and impact on patient-provider communication

Mobile sensors in cancer care: Patient and provider perspectives and
impact on patient-provider communication
This application is being submitted in response to the Notice of Special Interest (NOSI)
identified as NOT-CA-23-041. The goal of the parent grant, R37CA242545, is to develop
a system that uses smartphone and wearable sensors to passively monitor symptom
burden during chemotherapy. The parent study aims to develop machine learning
models predicting next-day symptoms using mobile sensor features as input, to
integrate these predictions into a patient-facing web application, and to evaluate the
feasibility and acceptability of using these predictions to trigger symptom self-
management advice or patient-provider communication. The proposed administrative
supplement will focus on understanding patient and provider preferences for
integrating mobile sensor-based metrics and predictions into clinical care in ways that
support patient-provider communication. We will conduct semi-structured and design
interviews with patients (n = 20) and providers (n = 20) that are participating in the
parent study, using purposive sampling to enroll both highly and less engaged
participants. We will develop several mid-fidelity prototypes that (1) visualize patients’
own sensor data from the parent grant and (2) visualize and explain sensor-based
predictions about next-day symptoms. Specific aims of this supplement are (1) to
identify barriers, benefits, and preferences related to how mobile sensor tools and data
could be used to support patient-provider communication during chemotherapy and
how to best support patient and provider use of these digital tools and (2) to obtain
patient and provider feedback on prototypes and visualizations. Findings from this
supplemental study will be used to support patient and provider engagement with our
mobile sensing system, to add new features supporting patient-provider
communication, and to address potential barriers to future implementation. Results will
also address a gap in the literature about how wearable and other passive sensors might
impact patient-provider communication and will inform future work integrating mobile
sensing into clinical cancer care.

Public health relevance
The proposed administrative supplement builds on an ongoing study developing machine learning models to predict real-time symptoms during chemotherapy using mobile sensor data as input. This supplemental work aims to identify patient- and provider-perceived barriers, benefits, and preferences related to how mobile sensor tools and data could be used to support patient-provider communication during chemotherapy and how to best support patient and provider use of these digital tools. Findings will address a gap in the literature about how wearable devices and other passive sensors might impact patient-provider communication and will inform future work integrating mobile sensing into clinical cancer care.